REDES: a peer network and mobile health (mHealth) enhanced CHW model to maximize COVID-19 vaccination among low income Latinos

Project Summary
The COVID-19 pandemic disproportionately impacts Latinos in the US. Failing to provide equitable access to
vaccines will exacerbate the profound disparities in COVID-19 and other health conditions among Latinos
communities. Our team has established a community coalition and identified effective interventions to reduce
disparities among low-income limited English proficiency (LEP) Latino communities using qualitative, survey,
and implementation science methodologies. We will test the efficacy of a combination intervention REDES
(“Networks”) - a social network and mobile health (mHealth) enhanced community health worker (CHW)
intervention - to address COVID-19 vaccine hesitancy and uptake among a cohort of Latinos and their
networks in Maryland. We will recruit 300 index participants who have taken the COVID-19 vaccine. Half of the
index participants will be randomized to the experimental group (n=150). CHWs will train them to be peer
mentors to conduct peer outreach in-person and by text messages and to promote vaccine acceptance and
uptake with their networks. Index participants in the control group (n=150) will receive an equal attention
intervention. In addition, we will recruit unvaccinated primary and secondary network members of indexes for
study participation and COVID-19 vaccination. We will enroll an estimated total of 1,590 primary and
secondary network members. All participants will be followed prospectively at 3, 6, 12, and 18 months after
baseline intake. The specific aims are: 1) Evaluate the efficacy of a combination intervention REDES to
promote COVID-19 vaccine uptake among Latinos; 2) Examine ongoing barriers and facilitators of vaccine
uptake among Latinos and their networks to tailor our intervention and address new challenges, and 3)
Evaluate the implementation determinants and outcomes of REDES to inform future broad-scale
implementation. Our multi-disciplinary research team brings together Latino health, social network, mHealth
interventions, vaccine hesitancy expertise; a long-term history of community engagement with partner
organizations in Maryland; and existing bilingual/bicultural CHW capacity and a rich local infrastructure for
COVID-19 response. If this combination intervention demonstrates the efficacy, we will develop an
implementation strategy toolkit, both in English and Spanish, for community partners and health departments
interested in replicating the approach. This proposal primarily focuses on COVID-19 vaccination, but
knowledge gained will be relevant to future vaccine equity initiatives, such as COVID-19 boosters (if needed)
and seasonal influenza vaccination.

Public health relevance
Project Narrative The proposed study is relevant to profound disparities in COVID-19 and other health conditions and lower coverage for all recommended adult vaccinations, including the COVID-19 vaccine among Latinos communities. This proposal will test the efficacy of a combination intervention REDES (“Networks”) - a social network and mobile health (mHealth) enhanced community health worker (CHW) intervention - to address COVID-19 vaccine hesitancy and uptake among a cohort of Latinos and their networks in Maryland. The proposed study will be the first to rigorously test a peer network and mHealth vaccine intervention integrated into state-of-the-art CHW-led community care for Latinos.